Cellular Systems Genetic Approaches to Understanding Regulatory Variation

PROJECT SUMMARY
The overarching goal of my laboratory is to determine how natural genetic variation influences
chromatin biology, cell fate, and, ultimately, phenotypic diversity. Since most disease-associated variants
occur in regulatory elements rather than coding genes, delineating the role of regulatory variation in normal health
and disease is a critical pursuit of modern genomics. Further, when variants disrupt gene regulation early in
development, it can lead to lasting defects in the structure and function of adult tissues. Regulatory element
function is determined by, and can be identified through, combinatorial sets of post-translational modifications
on chromatin. To understand how genetic variation impacts chromatin modification and function and results in
changes in development, we exploit the rich resources in mammalian diversity by deploying a novel cellular
systems genetics approach using stem cells to model cell fate and differentiation. In the past 5 years, we
established this innovative platform and developed a productive program to study how genetic variability in the
epigenome shapes chromatin organization, subsequent gene expression, and cell identity. Specifically, we
defined extensive trans-regulation of the pluripotent genome and identified genetically determined differentiation
propensity. The Baker lab is continuing to harness these collective strategies and build on these findings to
address the following gaps in our knowledge: What are the molecules and mechanisms underlying regulation of
the chromatin landscape? How does genetic variation influence chromatin structure and function? How does
variation in the establishment of the chromatin landscape impact differentiation and development? In the current
proposal, we will determine how the trans-regulation of chromatin impacts developmental disorders and answer
outstanding questions in the exaptation of transposable elements. We will develop tools to screen chromatin
regulators for their modification of developmental disorders and transposable element regulation. We will also
determine how genetic variation impacts expanded stem cell populations that contribute to extra-embryonic
tissue, improving the fidelity and reproducibility of ex vivo models of development. Together, this research
program will continue to shed light on the fundamental regulatory processes that shape genome function by
combining discovery-based approaches through cellular systems genetics and hypothesis-driven mechanistic
studies, which will be critical to fully realize the potential of regenerative medicine.

Public health relevance
PROJECT NARRATIVE Our bodies originate from the genetically controlled program of differentiation encoded in our DNA, starting from a single cell at fertilization. Variations in DNA sequences between individuals within a population can influence normal health and disease susceptibility by altering the regulation of genome organization and function during development. The goal of this proposal is to determine the molecular mechanisms by which this DNA sequence variation impacts cellular identity, cell fate, and developmental outcomes.